Coronary Artery Calcium in the PRagmatic EValuation of evENTs And Benefits of Lipid lowering in the Elderly: CAC PREVENTABLE Ancillary Study

ABSTRACT
Predicting risk is critical for effective primary prevention of atherosclerotic cardiovascular
disease (ASCVD), however classifying risk in adults ≥75 years of age remains extremely
challenging. Coronary artery calcium (CAC) scoring and high-sensitivity troponin (hs-Tn) are
promising tools for risk stratification in older adults because they provide singular and enduring
snapshots that directly quantify a composite of cumulative risk factor exposure and individual
resiliency or vulnerability. Used jointly, we have shown that low values of CAC and hs-Tn may
be useful for “de-risking” older populations, identifying individuals with highly favorable
prognosis in whom preventive therapy may not be beneficial. However, despite promising
observational data, the true clinical value of CAC and hs-Tn in older adults remains uncertain
due to lack of a dedicated, adequately powered randomized trial. The NIA/NHLBI-funded
PREVENTABLE (PRagmatic EValuation of evENTs And Benefits of Lipid-lowering in oldEr
adults) pragmatic clinical trial, which is currently randomizing 20,000 adults ≥75 years of age to
atorvastatin 40mg or placebo and following for ASCVD events, provides the ideal setting to test
the critical hypothesis that CAC and hs-Tn jointly identify older adults who will benefit the most,
and the least, from statin therapy. In this proposal, we seek to perform baseline CAC scanning
and hs-Tn measurement in 10,000 PREVENTABLE participants. At trial conclusion, we will
conduct analyses stratified by CAC, and jointly by CAC and hs-Tn, with >85% power to
determine heterogeneity of statin effect by biomarker status. At the end of the trial, we will
develop a comprehensive ASCVD risk classification model using traditional risk factors, CAC,
and hs-Tn and validate this in MESA and ARIC. We will then construct an online tool similar to
the LIFE-CVD model for calculating estimated benefit of statin therapy in the age ≥75 primary
prevention population, after detailed accounting for non-CVD competing risks observed in
PREVENTABLE. In summary, we believe that CAC scanning and hs-Tn measurement in
PREVENTABLE is the most expeditious and instructive way to fill critical knowledge gaps about
subclinical ASCVD in an older primary prevention population and to determine the value of a
biomarker-guided precision medicine approach for informing individual benefit of preventive
statin therapy.

Public health relevance
Project Narrative Demographic shifts, including longer life expectancy and a recent doubling of the older adult population, dictate an urgent need for evidence to guide risk assessment and clinical care of older adults with the dual goal of limiting overtreatment and maximizing treatment benefit. This study will evaluate the use coronary artery calcium, a measure of coronary atherosclerosis, and high-sensitivity troponin, as serum biomarker, as tools for potentially guiding selective statin therapy in adults over the age of 75. At the end of this study, we will make a risk score for predicting cardiovascular disease risk in older adults, and an online tool for estimating the cardiovascular disease-free life years gained from taking preventive statin therapy.